Deep South KUH Premier Research and Inter-disciplinary Mentored Education (PRIME) Professional Development Core

PROFESSIONAL DEVELOPMENT CORE SUMMARY
Augusta University, Tulane University, and the University of Alabama at Birmingham (UAB) have a strong well-
recognized culture of KUH investigators who promote professional development. The Deep South KUH Premier
Research and Inter-disciplinary Mentored Education (PRIME) Professional Development Core (PDC) will
implement a strategy for the inter-institutional and inter-disciplinary basic, translational, and clinical KUH
workforce with innovative programs. The overall goals of the PDC are to inspire and motivate the next
generation of scientific leaders, and, to sustain leadership within the Deep South KUH community. The PDC
provides an inclusive culture for all scholars and faculty underrepresented in medicine to succeed in an inter-
disciplinary environment. Aim 1. Establish a multi-dimensional, inter-disciplinary professional
development program of KUH trainees and early career investigators. The PDC will create a
multidimensional mentorship model for the Deep South KUH community to expand resources that includes
career coaches, near-peer activities and mentoring training at the KUH symposium, career development in team
science and entrepreneurship, and preceptor training in promoting a DEI culture. These personalized programs
include engaging coaches, role models, and mentors committed to participating in development of KUH trainees
and early stage investigators. To facilitate engagement, we developed inspirational forums and summer career
trajectory workshops to inspire and motivate KUH-themed career development that will sustain involvement in
the KUH community. Aim 2. Cultivate an inter-institutional KUH research culture for KUH trainees by
establishing an inter-disciplinary Scientific Mentoring And Research Training (iSMART) program. We will
enrich professional development of trainees through the iSMART program that will enhance scientific writing and
peer review effectiveness for KUH research. To sustain involvement in the KUH community, trainees will be
engaged as near-peer mentors, facilitators, and study section members for the subsequent cohorts of trainees.
Aim 3. Establish inter-disciplinary KUH scientific and mentoring development for early career
researchers through protected time for research training and research support. We will ensure
professional development of early stage investigators through the KUH Research Investigator Training (KUHR-
IT) institute providing one-on-one guidance that will enhance extramural applications for career development
awards and improve research methodology as well as establish the GAp year INternship (GAIN) program for
early career investigators. Early career investigators will serve as mentors, facilitators, and study section
members for the subsequent cohorts. The PDC provides innovative, immersive, and inter-disciplinary programs
for professional development with the NC, AC, and TL1 training core. In doing so, the Deep South KUH PRIME
will meet our mission to develop a diverse modern workforce of investigators who have the training and skills
necessary to advance KUH health through science and medicine.